Assessment of a Radiomics-Based Computer-Aided Diagnosis Tool for Cancer Risk Stratification of Pulmonary Nodules

PROJECT SUMMARY/ABSTRACT
This proposal describes a comprehensive 5-year mentored career development plan with the goal of training
the candidate to become a leading independent physician-scientist focused on improving the diagnostic
evaluation and management of pulmonary nodules (PNs) to optimize early detection of thoracic cancer and
minimize unnecessary harms to patients. The candidate is currently a Post-Doctoral Research Fellow and
Attending Pulmonologist at the University of Pennsylvania (Penn). The proposal builds upon Dr. Kim’s previous
research training in epidemiology and biostatistics and clinical experience in thoracic oncology. PNs are
commonly detected by computed tomography (CT). Lung biopsy, a highly invasive procedure, is required for a
definitive diagnosis but carries significant risks and costs. Thus, clinicians face the diagnostic challenge of PN
malignancy risk estimation when deciding which patients should undergo a biopsy, and which should be
surveilled with repeat imaging. The overall goal of this project is to address the current inadequacy of
estimating malignancy risk within the diagnostic process of PN evaluation by assessing the clinical utility and
effectiveness of a radiomics-based computer-aided diagnosis (CAD) tool. This novel technology synthesizes
quantitative features from raw CT imaging data invisible to the human eye and has been previously
demonstrated by the candidate’s team to improve clinicians’ PN diagnostic accuracy. This project’s goal will be
accomplished via three complementary specific aims. In Aim 1, a retrospective cohort study will be performed
to determine the clinical utility of a CAD-based risk stratification strategy using net reclassification indices,
decision curve analysis, and relative utility curves. In Aim 2, a pilot, single-center pragmatic randomized clinical
trial will be conducted to compare the clinical effectiveness of a CAD-based risk stratification strategy to usual
care for appropriate management of PNs, defined as biopsy or empiric treatment for malignant PNs and
surveillance for benign PNs. Finally, in Aim 3, the cost-effectiveness of a CAD-based risk stratification strategy
will be evaluated using decision analytic models for a simulated cohort of individuals with newly detected PNs.
Dr. Kim has outlined a rigorous training plan of coursework, skills acquisition (with a focus on clinical utility
analysis, clinical trial design, decision analytic modeling, and cost-effectiveness analysis), and professional
career development. To realize this vision, he has assembled a distinguished, multidisciplinary mentorship and
advisory team, led by his primary mentor, Dr. Anil Vachani, the Director of Clinical Research in the Section of
Interventional Pulmonology and Thoracic Oncology at Penn, and co-mentor, Dr. Katharine Rendle, Deputy
Director for Research at the Penn Center for Cancer Care Innovation. Penn provides an outstanding
intellectual, collaborative, and supportive environment for this proposal, positioning Dr. Kim to successfully
complete the aims and training plan so that he will be a competitive applicant for an R01 award to perform a
multicenter comparative effectiveness trial assessing PN malignancy risk stratification strategies.

Public health relevance
PROJECT NARRATIVE Pulmonary nodules (PNs) are detected via computed tomography (CT) in approximately 2 million adults in the U.S. each year, but the current diagnostic process for PN evaluation and management results in delayed cancer diagnoses and unnecessary invasive biopsy procedures among individuals with benign diagnoses. Existing clinical malignancy risk prediction models provide only modest diagnostic accuracy, but radiomics- based computer-aided diagnosis (CAD) tools, which synthesize quantitative features from CT imaging data to predict cancer risk, may help clinicians estimate PN malignancy risk more accurately. This proposal will evaluate the clinical utility, clinical effectiveness, and cost-effectiveness of a CAD-based risk stratification strategy for PN evaluation and management, with the goal of optimizing the PN diagnostic process to improve patient outcomes.